Fractality as a quantitative assessment tool for tic disorders and functional tic-like behaviors

Project summary
The natural history of tics is characterized by a high prevalence in boys, with onset around around 4‒6 years of
age. The initial tic symptoms are usually simple motor tics affecting the face, head, and neck. The first vocal tic
occurs on average a few years later, and is usually a simple vocal tic such as throat clearing or sniffing. If the
tics persist more than a year, the severity usually peaks around the age of 8 to 12 years. Most individuals with
tics undergo significant improvement or complete resolution before early adulthood. Recently, while tics in
patients with Tourette syndrome (TS) have been increasing rapidly, a different pattern has also been observed.
Some teenagers and young adults have experienced sudden onset of complex tic-like movements and
vocalizations. These patients differ significantly on several other features as well, and such distinct tic-like
behavior is now referred to as functional neurological symptom disorder with tics, or functional tic-like behavior
(FTLB). However, differentiating FTLB from typical tics is still challenging, and diagnosis and treatment are
important issues under active study in numerous centers worldwide.
Tic disorders are distinguished from other movement disorders not only by the phenomenology of individual
tics, but also by the timing of tics: they are neither rhythmic nor completely unpredictable. Rather, tics tend to
occur in clusters (several tic attacks within a few seconds, followed by an extended period of tic-free time). On
longer time scales, several bouts of tics may be followed by a relatively tic-free period with repeated episodes
grouped over minutes, and patients often describe a similar pattern over days or weeks. Based on this self-
similarity over different time scales, fractal timing of tics in TS was demonstrated over 20 years ago, and we
recently extended those results to both Provisional Tic Disorder and TS, applying a model from physics to
measure fractal dimension (Df) in relatively brief data sets (5 minutes). The Df of the tic time series correlates
with the tic severity, suggesting that Df may be useful as an objective indicator of tic severity.
We hypothesized that the fractal dimension Df of tics may distinguish FTLB from typical tics. Specifically, FTLB
may not show a fractal pattern, or the quantitatively measured fractal dimension may differ from that of typical
tics. The objective of this proposal is to investigate Df with the following specific aim: Df will be computed from
video samples of tics or FTLB, blind to diagnosis, contributed locally and from collaborators worldwide, and
compared to test this hypothesis. The long-term goal is to find an objective measure that distinguishes FLTB
from tic disorders, and if Df can be successfully demonstrated to differ between the two, future studies could
look at comorbidities, treatment, and how they change when healthy individuals mimic tics.

Public health relevance
Project narrative Functional neurological symptom disorder with tic-like movements and vocalizations (“FND-tic”) has appeared much more commonly over the past 3 years, and we hypothesize that not only the phenomenology but also the timing of symptoms in FND-tic differs substantially from the characteristic fractal timing of tics in Tourette syndrome. We will test this hypothesis on the timing of symptoms recorded blind to diagnosis from video recordings of patients with FND-tic and Tourette syndrome from our practice and from collaborators in the U.S. and internationally. A substantial difference in the quantitative fractal dimension of tics and functional tic-like symptoms would improve patient care for those with FND-tic and lead to further discoveries regarding the pathophysiology of tics and functional tic-like symptoms.